RENAL ERYTHROPOIETIN GENE EXPRESSION

The objectives are (1) to characterize the type of cell that produces erythropoietin in the kidney, and (2) to determine the gene sequences that control transcription and nuclear trans-acting factors that interact with these sequences. The methods include in vitro transcription systems using whole nuclei and nuclear extracts, transient expression analysis of transfected cell cultures, and DNase footprinting.